Integrated Health Sciences Facility Core

IHSFC PROJECT SUMMARY
Within the state of New Mexico, the health impacts (both individual and communal) from mining, metal
exposure as well as oil/gas/fracking activities are of considerable community concern. There is a broad range
of experience and extensive depth of knowledge that exists among the researchers and research teams
throughout the NM-INSPIRES Center investigators that can be directed toward addressing these community
environmental health concerns. The overall goal of the IHSFC is to work in partnership with all the Center’s
Cores and provide key infrastructure and support to actualize innovative translational and reverse
translational environmental health research that serves the communities of New Mexico. Environmental
health research currently conducted by NM-INSPIRES investigators generates data on a large number of
variables including environmental exposures, intermediate biological responses, and complex health
outcomes. The findings from this broad array of ongoing environmental, human and animal studies provides a
rich source of data to inform and inspire new translational or reverse-translational studies addressing complex
exposure-outcome relationships. The IHSFC will support the expansion and implementation of new
translational and reverse-translational research and capitalizes on the broad experience that exists within the
Center. The IHSFC team includes expertise in epidemiology, public health and toxicology to provide guidance
for study design to effectively address population risk factors and susceptibilities as well as potential
mechanisms that drive health outcomes. Specifically, the IHSFC will provide exceptional and complementary
scientific, technical and operational support to facilitate both new collaborations and initiatives through 1)
providing support for study design and implementation of population, clinical and laboratory based studies, 2)
overcoming institutional or regulatory bottlenecks, 3) facilitating access to existing data and samples from
ongoing environmental research to support or validate new initiatives. The specific experience within the
IHSFC team in implementing translational research studies will provide an infrastructure that does not
currently exist across the Center. The IHSFC will work to capitalize on the unique research background and
experience within the NM INSPIRES Center to expand our reach more broadly across New Mexico and build
on the strength of existing expertise, available resources to develop the infrastructure and create a value-
added synergistic service that will achieve Center objectives. The services and support provided by the
IHSFC provides a mechanism to continue to expand our excellent basic and translational research programs
in environmental health to serve our diverse community.